MPZL3 as a Therapeutically Targetable Mitochondrial Regulator of Sebaceous Gland Homeostasis and Sebum Production

Project Summary
Besides the production of sebum, which is essential for epidermal barrier function, skin elasticity,
thermoregulation and microbiome management, the sebaceous gland (SG) also exerts important
immunological, metabolic and (neuro)endocrine functions. Since dysregulated SG differentiation and sebum
production are seen in many skin diseases such as acne vulgaris, scarring alopecia, seborrheic dermatitis and
sebaceous tumors, the identification of central new molecular controls of SG differentiation and sebum
production will help to pinpoint new targets for therapeutic intervention for these skin diseases. The current
translational research project aims to identify myelin protein zero-like 3 (MPZL3) as a novel, therapeutically
targetable key regulator of SG homeostasis and sebum production via the control of sebocyte (SB)
proliferation and lipogenesis, in both murine and human skin. This project is based on our observation that
global knockout (GKO) mice for MPZL3, an essential mitochondrial regulator of epidermal differentiation, show
excessive sebum production, persistent SG hyperplasia and SB hyperproliferation. It will be the first to
interrogate the regulatory function of MPZL3 in a SG/SB biology context. Based on phenotype similarities
between Mpzl3 GKO mice and KO mice for PPARg, a key transcriptional regulator of SG differentiation, the
presence of putative PPARg responsive elements in MPZL3 regulatory sequence, and preliminary data
showing up-regulated Mpzl3 expression upon PPARg agonist treatment, we hypothesize that MPZL3 functions
immediately downstream of PPARg to regulate SB proliferation and differentiation. Aim 1 will identify changes
in SG homeostasis and sebum production upon global Mpzl3 deletion. Quantitative (immuno-)histomorpho-
metry and qRT-PCR, along with LCM-based RNAseq and pathway analysis will identify critical pathways
altered in Mpzl3 GKO skin. These results will be correlated with advanced lipidomics and proteomics analyses
by mass spectrometry to identify MPZL3-dependent changes in lipid pathways during SB differentiation. Aim 2
will distinguish epithelia-derived from extra-epithelial, MPZL3-dependent signals that regulate SG function by
comparing the SG phenotype in K14-Cre mediated, skin epithelia-specific Mpzl3 epiKO mice with GKO mice.
Aim 3 will determine the function of MPZL3 in human SBs and the regulation of MPZL3 function by PPARg
using in vitro (human SZ95 SBs), ex vivo (human skin organ culture) and novel human SG 3D organoids, as
well as in vivo models (Mpzl3 GKO and epiKO mice). Our studies will provide critical insights into the control of
murine and human SG physiology as being, at least in part, mitochondrially regulated via MPZL3. We expect to
identify MPZL3 as an innovative, drugable target for skin diseases associated with SG pathology and greatly
advance our understanding of the evolutionarily conserved functions of MPZL3 in mammalian skin biology.

Public health relevance
Project Narrative While sebaceous glands in our skin secrete an oily film (sebum) for skin lubrication, have multiple other indispensable functions, and are involved in many skin diseases, it is still quite unclear how they are regulated. Therefore, we aim to identify the role of a powerful regulatory protein located in mitochondria, the energy power houses of our cells, called MPZL3, in regulating sebaceous gland function, using state-of-the-art mouse and human skin research tools. Besides helping us to better understand how healthy sebaceous gland functions are regulated, the innovative skin research focusing on MPZL3 proposed here also promises to identify novel drug targets for more effective and better-tolerated treatment of human skin diseases with prominent sebaceous gland abnormalities such as acne, dry skin, scarring alopecia (hair loss) and sebaceous carcinoma.